Role of Tim-3:Bat-3 pathway in inducing tolerogenic DCs and peripheral tolerance

PROJECT SUMMARY:
First cloned in our laboratory, TIM-3 is a hallmark of T cell exhaustion and dysfunction in murine and human
chronic viral infections and cancer. Since its discovery, TIM-3 has been recognized as an important negative
regulator of T cell functions, which has formed the basis for checkpoint blockade immunotherapies being
developed for cancers. Our recent studies suggest that TIM-3 also antagonizes the expression of TCF1, a
crucial transcription factor expressed by a recently discovered subset of T cells with stem-like properties that
are the source of effector T cells. However, TIM-3 is also highly expressed on dendritic cells (DCs). Despite
the high levels expressed on DCs, the role of TIM-3 in these cells remains unclear. The focus of this renewal
is on TIM-3 expression in DCs and how this co-inhibitory molecule regulates DC functions and orchestrates
the priming and fate of T cells.
To interrogate TIM-3-mediated effects on DC functions, we have generated mice in which TIM-3 deficiency
is restricted to DCs. Initial studies with these conditional knockout mice revealed that TIM-3 expressed on
DCs is pivotal in immune regulation, including in autoimmune diseases and cancer. While we have known
that mice deficient in TIM-3 develop more severe experimental autoimmune encephalomyelitis (EAE) and
are better at suppressing tumor growth, our published and preliminary findings indicate that TIM-3 expressed
on DCs, has profound effects on these disease outcomes. In these experimental models, we found that mice
with DC-specific loss of TIM-3 generated an expanded pool of stem-like CD4+ T cells. Further investigation
revealed that multiple pathways, including inflammasome and cGAS-STING, were perturbed in TIM-3-
deficient DCs upon activation.
These observations led us to hypothesize that TIM-3 curbs the activation of DCs with functional implications
for the generation and maintenance of autoreactive stem-like CD4+ T cells. Uncovering the molecular
mechanisms by which TIM-3 exerts its effects on DC functions and influences T-cell-mediated immunity has
fundamental and therapeutic importance. Thus, to test this hypothesis, we propose two specific aims to: 1)
elucidate the functions of TIM-3 in DCs that impact the generation of stem-like autoreactive CD4+ T
cells driving CNS autoimmunity, and 2) uncover the molecular mechanisms underlying TIM-
3:Inflammasome crosstalk and its impact on CNS autoimmunity.
Using an extensive suite of mutant mouse lines, we outline experiments that will tease apart the TIM-3-
mediated molecular interactions between DCs and T cells during CNS autoimmunity and build on the
advances made during the previous grant cycle. By combining the power of sequencing and CRISPR/Cas9
genetic screening with in vitro functional assays and in vivo disease models, we will explore how TIM-3
signaling regulates DC function and generation of autoreactive stem-like T cells. The proposed studies will
provide a greater understanding of the contribution of cell-intrinsic and -extrinsic effects of TIM-3 in DCs on
the development and persistence of autoimmunity.

Public health relevance
PROJECT NARRATIVE Besides being expressed on T cells, TIM-3 is highly expressed in dendritic cells (DCs). Extensive research has amassed establishing TIM-3 as a negative regulator of T cell effector functions and driver of T cell exhaustion in multiple diseases – including chronic viral infections and cancer – but in DCs, the role of TIM-3 has not been well studied. This proposal will provide valuable molecular insight into the role of TIM-3 in mediating DC functions and their effects on T cell priming and function, which can be exploited to design more effective therapies for treating autoimmune diseases.